Hologic DXA Scanner

Project Summary/Abstract: The Horizon DXA total body scan system uses state-of-the-art
technology and dual energy X-ray absorptiometry (DEXA) a low radiation technology that
measures precise assessment of targeted body composition, bone mineral density, and a 10-
year projected fracture risk. It also includes the capability to capture an image of the abdominal
aortic calcification or plaque buildup. The scanner is non-invasive and produces rapid results
within 5-minutes and delivers easy-to-read reports and is suitable for individuals ages 3 and up,
making it possible to expand our educational and research opportunities, making our institution
more competitive in the biomedical and health science areas. Purchasing this advanced
scanning system is of utmost importance in achieving the institution's long-term goal of
becoming a core facility for metabolic health and aging research and education in this area.
The DXA scanner aligns with our long-term educational goals to 1) strengthen our biomedical
and health science education course offerings and provide students with invaluable hands-on
training using advanced technology, allowing us to be more competitive and better prepare
students for careers in a wider scope in health care and research fields 2) enhance student and
faculty recruitment and retention by providing unique opportunities for clinical, research, and
practical training using advanced technologies.
Additionally, the DXA body scanner will strengthen the opportunities for research
collaborations by 3) providing increased opportunities for cutting edge research in the field of
biomedical and health sciences 4) increasing opportunities for interdisciplinary collaborations
among students, faculty, staff, and health professionals from various fields including nutrition,
public health, biology, engineering, nursing, psychology, and athletics 5) allow for networking
partnerships with external institutions, including hospitals, clinics, and neighboring universities.
Lastly, this DXA scanner will strengthen our commitment to health prevention in our
community by 6) expanding our ability to provide comprehensive health screenings to the
underserved members of our rural community 7) supporting student athlete’s physical and
mental health by better-managing of stress fractures and swiftly handling of injuries in-house,
thereby eliminating the need to travel to the closest orthopedic clinic over an hour away.

Public health relevance
Project Narrative: The DXA scanner is essential for us to recruit & retain faculty and students into our public health, health sciences, and biomedical areas and continue to provide health screenings to our underserved community. We are the only body composition scan in 90-miles.